Administrative Core

Administrative Core Summary/Abstract
The main goals of the Administrative Core would be to 1) organize weekly Research Progress meetings, 2) host
external seminar speakers, 3) provide public outreach and website support, 4) ensure training in rigor &
reproducibility of investigators working within the NIDA-P30 Center, 5) facilitate training and professional
development of students and fellows 6) increase access to NIDA P30 resources and training for people from
diverse backgrounds, and 7) archive complete data sets underlying publications generated by the NIDA-P30
Center and facilitate sharing of resources generated by the NIDA-P30 Center. The NIDA-P30 Center would
solicit input from External and Internal Advisors who would help ensure strategic and fair allocation of shared
resources, guide training sessions, and select and monitor the progress of Pilot Projects. The Administrative
Core would monitor budgets to ensure that expenditures match the projections, ensure compliance with
Environmental Health & Safety, IACUC, and OSHA rules for the Core Spaces, make the travel arrangements
and meeting schedules of our External Advisors when they visit the UW Addiction Center, and provide up-to-
date information about Seminars and meetings for the NIDA-P30 Investigators and resource availability.